COBRE in Digestive and Liver Disease

Animal Models of Digestive Disease Core – Project Summary
The objective of the Medical University of South Carolina (MUSC) Center of Biomedical Research Excellence
(COBRE) in Digestive & Liver Disease (CDLD) is to enhance research infrastructure and expand research
capacity to enable outstanding and collaborative biomedical research in digestive and liver diseases. The Animal
Models of Digestive Disease Core has helped begin to establish and will sustain the CDLD as the driving force
for digestive and liver diseases research at MUSC through the provision of highly specialized and high quality
Core resources.
Performance of digestive disease research requires utilization of unique and complex models of disease. Thus,
we have developed the Animal Models of Digestive Disease Core to specifically support CDLD Research Project
Leaders (RPLs) and all MUSC digestive disease researchers with a distinctive, unified, and skilled Facility that
provides access to essential animal models and guidance on research project planning and implementation.
This Core currently leverages and will continue to leverage existing resources and expertise within the MUSC
Division of Laboratory Animal Resources (DLAR) in order to efficiently provide and support in vivo models of
digestive disease. Core leaders will offer CDLD researchers specialized knowledge, mentorship and training on
animal models so that they obtain sufficient, high quality data for their projects, which will then form the basis of
their successful competition for future independent extramural funding. It should be pointed out that while
supporting RPLs’ research is a primary objective for the MUSC CDLD and the AMDDC, all investigators at MUSC
will have access to the models, resources, and training that the Core provides. This is expected to support the
overarching COBRE vision by enhancing MUSC’s research infrastructure.
To achieve the stated objective, the AMDDC will focus on 2 distinct but related specific aims in Phase 2 as
follows: 1) the Core will continue to provide animal models of digestive and liver diseases and 2) a state of the
art gnotobiotics facility. In addition, the Core utilizes and will continue to utilize a highly effective 1:1 training
and mentoring approach. Members of this Core are skilled and highly experienced, supporting the generation
of high quality data and life-long learning for CDLD Members.